Effects of alcohol-induced dysregulation of lung hyaluronic acid

PROJECT SUMMARY/ABSTRACT
Ethanol (EtOH) misuse is linked to over 5 million annual deaths globally, partly due to increased risk of
developing respiratory infections and acute respiratory distress syndrome. Alveolar macrophages (AM), the
first line of defense against pathogens in the lower respiratory tract, have impaired bioenergetic and phagocytic
capabilities following chronic alcohol exposure. EtOH increases oxidative stress in the alveolar space and
mitochondrial (MT)-derived oxidative stress in AM. Chronic oxidative stress disrupts redox signaling and
induces molecular damage. Hyaluronic acid (HA) is an extracellular matrix polysaccharide produced in the
alveolar space by pneumocytes and resident macrophages. Although evidence suggests that AM immunity
and HA molecular weight/function are each negatively influenced by oxidative stress, their interactions have
never been explored in the context of alcohol misuse. The objective of the proposed studies is to investigate
the underlying mechanisms of EtOH-induced AM dysfunction due to intra- and extracellular oxidative stress.
These studies will focus specifically on EtOH-induced redox imbalance and its effect on HA synthesis,
degradation, and inflammatory signaling in the AM. Mechanistic studies will explore if perturbed HA synthesis,
degradation, or signaling impact mitochondrial function and energy metabolism. Our overarching hypotheses
is that EtOH-induced oxidative stress and altered MT function impair AM phagocytic capabilities by
modulating HA dynamics.
To test our hypothesis, we will use established murine in vitro and in vivo chronic EtOH consumption
models to determine how HA modulates MT bioenergetics and AM phagocytosis and how EtOH-induced
oxidative stress modulates HA dynamics. Aim 1 studies will focus on the effects of HA binding proteins and
downstream signaling pathways on expression of key MT regulators, MT bioenergetics, and AM phagocytosis.
Aim 2 studies will focus on how EtOH-induced lung redox imbalance results in HA disruptions in the AM. Lung
HA concentrations will be correlated with AM oxidative stress. EtOH-induced lung oxidative stress and AM MT-
derived oxidative stress will be targeted using pioglitazone, a peroxisome proliferator-activated receptor
gamma ligand with antioxidant properties. The role of HA in EtOH-induced AM dysfunction is unexplored and
significant in delineating this pathology. Novel pathways identified in these studies could shift scientific and
therapeutic paradigms by identifying perturbed HA dynamics as a therapeutic target. This proposal will provide
an invaluable training opportunity for the applicant and provide potential therapeutic strategies to target HA
dynamics to prevent EtOH-induced impairments in AM phagocytosis and resultant pulmonary injury. These
studies are not only important to investigate the mechanisms of impaired lung immunity due to alcohol misuse
but may also provide valuable insights into HA derangements in several other pulmonary diseases including
coronavirus disease 2019, pneumonia, and asthma.

Public health relevance
PROJECT NARRATIVE Alveolar macrophages phagocytose pathogens and are the first cellular line of defense in the alveolar space, but chronic alcohol consumption diminishes alveolar macrophage phagocytic ability through increased lung oxidative stress. Hyaluronic acid is also altered by oxidative stress and plays a role in lung immunity and inflammation. This proposal aims to understand how alcohol misuse dysregulates hyaluronic acid and impairs alveolar macrophage immune function.